Improved Electrochemical Biosensors using Engineered Binding Proteins

Project Summary
The goal of this project is to develop a new class of electrochemical biosensors that use engineered
binding proteins to simplify fabrication and improve performance. Electrochemical sensors have the
potential to provide inexpensive, sensitive, quantitative diagnostic assays. However, there are few success
stories in commercial electrochemical sensors outside enzymatic systems (e.g. glucometers), particularly in
electrochemical immunosensors. Immunoassays provide actionable information about health and a wide array
of diseases. Immunosensors use pairs of antibodies rather than an enzyme to recognize targets, and targets
are typically present at much lower concentrations than glucose, making the analytical problem more
challenging. Impactful, widely used immunoassays such as pregnancy and covid tests have had optical rather
than electrochemical readouts. Electrochemical immunosensors would be advantageous, as they can be
sensitive and quantitative, avoiding subjective interpretation, and can connect with affordable consumer
electronics for longitudinal monitoring of conditions. A major obstacle to progress has been the
development of a reproducible electrode modification strategy that can be readily adapted to large-
scale manufacturing while maintaining sensitivity and specificity. Current methods for antibody
immobilization rely on adsorption, electrostatic deposition/entrapment, and/or covalent tethering. Each method
has limitations, such as significant loss of antibody function, difficulty achieving reproducible coatings, and
reduced sensitivity due to thick coating layers that diminish electrical signals. In recent years, small,
engineered binding proteins have been developed that contain material-binding domains on one side and
target binding domains on the opposite side. This approach can generate better sensitivity in shorter assay
times, higher stability, and easier fabrication than systems using antibodies and traditional deposition methods.
However, the vast majority of these efforts have focused on paper tests with optical detection methods. We
hypothesize that engineered binding proteins can be used to enhance the performance of electrochemical
biosensors relative to traditional electrode modification procedures for carbon composite and laser-induced
graphene electrodes. To test this hypothesis, we will 1) develop immunosensors made using engineered
binding proteins that target polystyrene in the electrode on one side and protein A on the other to generate
surfaces that properly orient antibodies and 2) develop immunosensors with proteins that bind laser-induced
graphene on one side and the target analytes on the other end. The outcome of this project will be a new
approach to creating electrochemical immunosensors that is faster and easier than current approaches while
generating higher performance.

Public health relevance
Project Narrative Electrochemical immunosensors have significant potential to rapidly, sensitively, and quantitatively analyze biomarkers in complex biological samples, however, current methods for modifying electrodes rely on either covalent attachment procedures that yield high performance but are difficult to scale beyond laboratory prototypes, or simple fabrication procedures that can be scaled easily but give poor sensor performance. In the proposed project, we will demonstrate the first use of small, engineered binding proteins to create electrochemical immunosensors where one end of the protein binds to the electrode surface and the other end binds the target. This novel approach to electrode modification will improve performance while reducing fabrication complexity to enable mass production of sensors.